Targeting the Genus Leishmania with Small Molecules

PROJECT SUMMARY AND ABSTRACT
Targeting the Genus Leishmania with Small Molecules
Leishmaniasis is a neglected disease caused by protozoan parasites from the genus Leishmania sp. It
is transmitted by the sandfly vector and manifests in different clinical forms including skin ulcers, mucosa
destruction, damage to visceral organs such as the liver and spleen, and bone marrow damage. The clinical
outcome is determined primarily by the species of the parasite and the immune system of the host. There are
98 countries affected by leishmaniasis with more than 2 million people currently infected and 350 million people
at risk. The spread of leishmaniasis is of particular concern to US citizens in southern states such as Texas and
Oklahoma, where cases have recently been reported, as well as to US military troops stationed abroad in
geopolitically unstable regions where the disease tends to thrive.
Chemotherapy options for leishmaniasis are limited. Antimonials have been the first line drug for decades
in most endemic countries, despite antimony’s notorious adverse effects, hospitalization requirements and
increasing cases of antimony-resistant parasites. Amphotericin B, the main alternative treatment, also causes
significant harmful side effects. Liposomal formulations are better tolerated, but are prohibitively expensive for
most affected populations. Miltefosine, an anti-cancer drug, was recently repurposed to treat leishmaniasis and
is the only oral treatment available and approved for use in the US. Miltefosine also has toxicity limitations,
teratogenicity and lack of efficacy against certain Leishmania species. The development of new chemotherapies
to treat the different clinical forms of leishmaniasis is in urgent demand, and is clearly an unmet medical need.
To address this unmet medical need, Scott Schaus and Lauren Brown from Boston University (BU) will
lead a collaborative project with Jair Lage Siqueira-Neto at the UC San Diego Center for Discovery and
Innovation in Parasitic Diseases (CDIPD), Camila Indiani de Oliveira at FIOCRUZ and Mark Grinstaff at BU to
characterize the activity of antileishmanial small molecules and develop them as systemic and topical
therapeutics. Preliminary work by the team has led to the identification of a chemotype with nanomolar in vitro
efficacy against both visceral- and cutaneous-causative species of the parasite, a suitable pharmacokinetic
profile for in vivo studies, and demonstrated in vivo efficacy in a cutaneous leishmaniasis infection model.
This grant outlines a proposal to further develop the chemotype and address specific challenges in
antileishmanial drug discovery, including drug target identification, options for dosing and administration, and
most importantly the applicability of the chemotype to treat multiple manifestations of the disease, including those
that are most relevant and endemic to the American continents. Our end goal is to develop at least one pre-
clinical candidate for the treatment of either visceral or cutaneous leishmaniasis.

Public health relevance
PROJECT NARRATIVE Targeting the Genus Leishmania with Small Molecules Our research focus is the development of a new therapy for the parasitic disease leishmaniasis. We have a proof-of-concept and preliminary structure activity relationships (SAR) validating a new antileishmanial chemotype, and the overarching project goal is to expand this SAR and optimize the compounds and their formulations to evaluate lead drug candidates against the disease’s two different clinical manifestations: visceral leishmaniasis and cutaneous leishmaniasis. The work scope will also include important mechanism-of-action and target deconvolution studies that will contribute basic knowledge to the field of leishmania parasitology.